Understanding the genomic basis of post-traumatic stress disorder through integrative analysis of rare variants and other omics data

ABSTRACT
Posttraumatic stress disorder (PTSD) is a commonly occurring condition following exposure to traumatic events
with significant clinical, quality of life, and economic impact. PTSD is moderately heritable. Significant advances
have been made through efforts of consortia and large-scale genetic studies to shift PTSD from a disorder with
low genetic discoverability to one with a growing number of identified, replicable common genetic variants and
significant genetic correlations with other neuropsychiatric and substance use disorders. In addition, the
integration of multi-omics approaches (i.e., information from the genome, epigenome, proteome, and
transcriptome) has identified pathways and tissues associated with the disorder. Rare non-coding functional
variants are also an important component of genetic risk. The integration of rare variants with common variants
into these multi-omics approaches has not to date been done for PTSD. The proposed study seeks to fill this
gap by building upon prior work by our group 1) observing rare-variant based genes and pathways associated
with PTSD from a pilot study using a whole exome sequencing (WES) dataset, and 2) identifying additional
genes associated with other neuropsychiatric and substance use disorders by integrating rare variants from WES
datasets and other omics datasets. We aim to leverage existing large-scale WES and whole genome sequencing
(WGS) datasets and biorepositories and use these integrative approaches to identify additional genetic signals
for PTSD. To do so, we will develop analytic pipelines to analyze available datasets for PTSD phenotypes from
the UK Biobank (500K WES/WGS) and the All of Us study (245K WGS). Our analyses will impute, harmonize,
and integrate phenotypic information available from these select biobanks to increase sample sizes and in turn
power to detect effects and prioritize genes associated with PTSD using rare variant information from WES/WGS
data. We further propose to jointly analyze existing gene-sets associated with PTSD with rare variants from
sequencing data to improve genetic detection. We will also leverage the genetic correlation among other
conditions to increase statistical power by jointly analyzing sequencing datasets of PTSD and other comorbid
disorders. The overarching goal of this work is to integrate rare variants from large scale sequencing biobank
datasets and available omics information to capitalize on the full frequency spectrum of variants to identify
additional, novel genetic signals associated with PTSD. The knowledge gained and pipelines developed from
study goals will be critical for future R01-scale efforts to extend this approach to other datasets and phenotypes
and identify targets for prevention and treatment of PTSD.

Public health relevance
PROJECT NARRATIVE Posttraumatic Stress Disorder (PTSD) is a moderately heritable, common condition with substantial clinical and economic burden. Although replicable common genetic variants have been identified, rare genetic variation has yet to be systematically studied for this disorder, despite the availability of large-scale genomic datasets from biobanks and consortia; thus, this project aims to integrate the information of rare variants from select whole- exome and whole-genome datasets along with other omics and public datasets using novel integrative approaches to prioritize 1) additional genetic signals for PTSD, and 2) shared genetic signals between PTSD and other neuropsychiatric disorders. Results from the project will increase power to help identify novel genetic signals associated with PTSD to improve our understanding of the genetic architecture of PTSD and its comorbidity with other conditions and pave the way for future precision medicine studies.